Deep Brain Stimulation in Laryngeal Dystonia and Voice Tremor

PROJECT SUMMARY / ABSTRACT
Loss of voice control, which is critical for conveying effective spoken communication, is often a significant
feature in patients with movement disorders, such as dystonia and essential tremor. Voice dysfunction,
however, has been overshadowed clinically by a focus on limb motor symptoms. For example, deep brain
stimulation (DBS) effectively reduces limb dystonia and tremor in these patients, but the modulation of voice
symptoms by DBS has been vastly understudied. It is assumed that the production and modulation of voice are
regulated by the basal ganglia-thalamo-cortical network in a loop architecture that is common to all motor
behaviors. There is, however, little empirical data to inform our specific understanding of how voice function is
encoded in basal ganglia-thalamo-cortical interactions. The overall goal of this Project is to use a
combination of invasive and non-invasive human neuroscience to improve our understanding of the
incidence and neural correlates of neurological voice disorders (laryngeal dystonia and voice tremor)
in patients with isolated dystonia and essential tremor undergoing DBS surgery. We will use
simultaneous electrocorticography (ECoG) and subcortical activity recording in dystonia and tremor patients
who are awake and speaking during DBS implantation surgery. We will supplement these data with non-
invasive, multimodal scalp magneto/electroencephalography (M/EEG) and functional MRI (fMRI) recordings
before DBS surgery and longitudinal M/EEG recordings within one year after surgery to enhance our
understanding of DBS-induced neural network modulation relevant to voice motor symptoms in dystonia and
tremor patients. This work will be facilitated by the fact that all participating Center sites already use the same
equipment and techniques for DBS implantation and will follow standardized experimental protocols. The
disorder-specific intracranial neurophysiological signatures will be correlated with non-invasive imaging
findings, stimulation location defined connectivity maps, and voice outcomes. The results of this Project will
inform the development of strategies for closed-loop brain stimulation specifically to treat neurological voice
dysfunction that can be tested in a subsequent clinical trial.

Public health relevance
PROJECT NARRATIVE Loss of voice control, which is critical for conveying effective spoken communication, is often a significant symptom in patients with movement disorders. The goals of this project are 1) to determine the incidence of neurological voice disorders in patients with dystonia and essential tremor undergoing deep brain stimulation (DBS), 2) investigate the neuroimaging and intracranial neurophysiology correlates of voice dysfunction in these subjects, and subsequently 3) determine the effects of DBS on voice function. This research is relevant to NIH’s mission that pertains to developing fundamental knowledge that will help reduce the burdens of human disability.